Non uniformity in the PDL: structure and function of the dense collar

ABSTRACT:
Teeth function under high repetitive masticatory loads throughout lifetime. They need to quickly adapt to food in
different sizes and consistencies in order to enable an efficient masticatory process. This quick adaptation
capability is provided by a unique soft tissue that connects the tooth to the alveolar bone, the periodontal ligament
(PDL). The PDL, therefore, is critical for proper tooth function and survival. At present, there are different
solutions for restoring teeth and alveolar bone structure to different extents but no predictable methods exist for
restoring the PDL. This proposal will establish a platform for a regeneration therapy for the PDL. The PDL is a
non-uniform tissue, we recently identify a unique structure of dense collagen network at the most coronal part of
the PDL and coined the term dense collar. This region is consists of dense, short horizontal fibers with a
directionality preference that corresponds to natural drift direction of the tooth. Our recent studies show higher
stiffness of the dense collar when compared to the furcation region in the PDL as well as unique composition.
We therefore hypothesize that the dense collar is a central contributor to the overall tooth stability and therefore
any impairment to the dense collar structure will affect the entire PDL function. To test this hypothesis we will
take a multidisciplinary approach investigating the structure and function of this tissue and its role in the entire
PDL function and tooth stability. We will generate a base line of the ECM and cellular profile of this region in
comparison to other regions in the PDL using localized proteomics and mass cytometry. We will measure the
mechanical properties of the dense collar using high frequency AFM and tooth mobility using an in-situ loading
device and we will unravel the collagen structure using a novel in-situ Raman spectroscopy and our microCT
based method for soft tissue imaging. We will combine theses cutting edge methodologies utilizing unfixed
samples with minimal sectioning to enable sample collection with their 3D structural context. We will then test
the effect of different interventions to the structural integrity of the dense collar on tooth mobility. We will use a
modified pre-periodontitis model and orthodontic tooth movement in mice model and compare the structural and
mechanical properties of the dense collar to the base line. In the last stage we will identify a method to strengthen
the dense collar to increase tooth stability. This proposal will determine the role of the dense collar in tooth
stability and the association between structural changes in the dense collar and overall PDL function. Most
importantly, unraveling the structure and function of a specific region within the PDL will generate a platform for
structural interventions to reinforce this region and control the entire PDL function and tooth stability. This
proposal will lay the ground to a paradigm shift in different dental fields such as orthodontics, dental trauma, and
periodontics.

Public health relevance
Narrative: This proposed research will explore the structure and function of a new feature we recently discovered in the PDL, the dense collar. We hypothesize this unique structure controls tooth stability and therefore we will establish a thorough understanding of the structure and function in health as well as in compromised state such as in periodontitis and orthodontic tooth movement. Identifying a specific region within the PDL that is directly linked to tooth stability will generate a paradigm shift in regenerative therapies for periodontitis as well as new approaches to generate orthodontic tooth movement.